Testing effects of cash transfers on biological aging and risk for Alzheimer's Disease

Alzheimer's Disease (AD) and AD-Related Disorders (AD/ADRD) are significantly increasing in
resource-limited areas, where improved nutrition and decreased infectious disease mortality are
enabling population aging. Simultaneously, enduring elevated levels of early-life adversity and
adult hardship accelerates the development of aging-related diseases like AD/ADRD.
Interventions are needed to reduce disease burden and increase healthy lifespan. Cash transfer
programs are proven to reduce mortality in these settings. However, their impact on risk for
chronic diseases of aging remains unclear. We propose a novel method to address this
knowledge gap: epigenetic clock analysis of the pace and progress of biological aging.
Epigenetic clocks can reveal otherwise occult health risks in young adults and forecast long-
term disease outcomes, including AD/ADRD. Our study will assay dried bloodspot
biospecimens from 4,000 participants in a randomized controlled trial of an unconditional cash
transfer program, and test if transfers can slow biological aging. We will also investigate the role
of immune aging, a crucial AD/ADRD risk driver, and quantify associations of epigenetic clock
and immune aging measures with early AD/ADRD risk factors. Our study will be among the first
to characterize epigenetic-clock and immune aging phenotypes in a low-resource-setting cohort,
to test cash-transfer effects on biological aging, and to examine how biological and immune
aging relate to cognitive functioning and AD/ADRD risk factors in a low resource setting. This
innovative study will conduct a rigorous test of a cash transfer program's impact on biological
aging, cognition, and AD/ADRD risk, providing insights for developing strategies to extend
healthy life years and reduce AD/ADRD risk.

Public health relevance
The primary objectives of this project are to assess the effects of a cash transfer program on the slowing of biological aging and reduction of dementia risk in younger and older individuals. Additionally, we aim to quantify associations between biological aging and cognitive function in this population. Results of this research could have substantial impact for public health by revealing causal, long-term consequences of economic interventions for health and cognitive aging. Moreover, it will generate new knowledge about biological aging and Alzheimer’s Disease risk in low resource settings.